Early brain monitoring of infants with prenatal opioid exposure using quantitative diffuse optical spectroscopy

Abstract
The incidence of infants with prenatal opioid exposure (POE) has increased significantly in the
last decade. Infants exposed to opioids prenatally are at risk for poor cognitive, behavioral, and
neurodevelopmental outcomes later in life. Moreover, a large percentage of infants with POE
exhibit a broad variety of neonatal opioid withdrawal symptoms (NOWS) that range from mild to
severe. Currently, there is no objective strategy to identify severity and/or guide clinical
intervention for NOWS, leading to prolonged hospital stays and delayed treatment. The absence
of a unified management strategy is partly due to a lack of quantitative tools to objectively identify
NOWS biomarkers in the first days of life.
MRI studies linking brain abnormalities with prenatal opioid exposure suggest that cerebral
physiology could serve as an early biomarker, but logistical challenges limit its use. Optical
techniques like near-infrared spectroscopy (NIRS) offer a non-invasive and cost-effective
alternative, but commercial devices are limited in providing a comprehensive profile of cerebral
physiology. This project proposes using a novel hybrid device that combines frequency-domain
NIRS (FD-NIRS) and diffuse correlation spectroscopy (DCS) to quantify cerebral oxygenation and
cerebral blood flow in neonates. While similar in concept and ease of use to standard FDA-
approved cerebral oximeters, our approach is more advanced because it can estimate cerebral
oxygen metabolism by combining cerebral oxygenation and cerebral blood flow measurements.
In this study, we propose to acquire longitudinal FD-NIRS/DCS measurements on infants with
POE and controls to determine early differences in cerebral physiology in the first week of life
(Aim 1), evaluate their associations with short-term clinical outcomes (Aim 2), and monitor
potential changes in cerebral physiology in response to pharmacologic treatment for severe
NOWS (Aim 3). No prior study has assessed the potential of bedside measures of cerebral
physiology to screen neonates with POE and/or NOWS. Successful completion of our research
will offer new insights into the underlying pathophysiology of early brain changes resulting from
POE and demonstrate the prognostic value of longitudinal FD-NIRS/DCS measurements for early
assessment of NOWS severity in individual neonates. This could potentially improve symptom
monitoring and guide personalized treatment, ultimately enhancing the care of newborns with
NOWS.

Public health relevance
Narrative There is a crucial need for objective tools to monitor and guide treatment in infants with prenatal opioid exposure (POE) who develop neonatal abstinence syndrome (NOWS). Advanced optical techniques like FD-NIRS/DCS can offer early biomarkers of cerebral physiology, providing critical data during the first days of life. This project aims to demonstrate the feasibility of using FD- NIRS/DCS to detect early changes in cerebral physiology associated with POE and assess NOWS severity in individual infants, thereby advancing personalized treatment strategies for this vulnerable and understudied population.